Coordinating center for the NCI small cell lung cancer research consortium

ABSTRACT
The overarching goal of the NCI Small Cell Lung Cancer (SCLC) Coordinating Center has been to “break the
logjam” of fundamental knowledge gaps resulting in a 30+ year lack of progress on this lethal malignancy that
was designated a “recalcitrant cancer” by the US Congress and NCI. Our U24 Coordinating Center has done
this by promoting and facilitating information sharing, interaction, and collaborative research among NCI-
supported investigators studying SCLC. Over our initial five years of support, this Coordinating Center has
significantly increased research progress within the SCLC research community through efforts including, but not
limited to, the creation and ongoing expansion of comprehensive preclinical and clinical -omics databases,
centralized annotation and cataloging of available SCLC models, distribution and sharing of such models,
centralized data analytics, a centralized Consortium website, initiation and coordination of an interactive work-
in-progress (“WIPs”) forum as well as planning and oversight of annual meetings. Of all of this, the role of the
Coordinating Center in facilitating interactive WIPs (usually with ~100 attendees from dozens of institutions
including patient advocates) with unprecedented information and resource sharing, has made possible
tremendous progress in overcoming knowledge gaps, all of which are documented in a large number of peer
reviewed publications. This renewal application will continue the exceptional research momentum the SCLC
Consortium has generated, and build on this initial success through support of new initiatives. These include
centralized support for databasing and comparative analysis of genetically-engineered mouse models (GEMMs),
and multi-parameter characterization of patient-derived xenograft models developed across the Consortium.
These additional resources will be of direct utility to the SCLC research community. As part of the U24 renewal,
given the remarkable growth in scope and diversity of SCLC research, we have developed a new multi-PI
structure including Charles Rudin (MSK), John Minna (UTSW), with addition of two exciting young SCLC
investigators who have contributed important new insights into SCLC molecular and cellular biology - Trudy
Oliver (University of Utah), and Lauren Byers (MDACC). All four have been personally very active both in the
U24 activities and in their own individual SCLC U01 and R01 research. The complementary strengths of this
leadership team cover all of the important areas of SCLC basic, translational, and clinical trials research. Dr.
Rudin will continue as contact PI, providing administrative leadership and coordination. We emphasize that the
products of the Consortium will ultimately benefit human health through fostering development of novel strategies
for disease prevention, early intervention, immune surveillance, metastasis suppression, and therapeutics.

Public health relevance
PROJECT NARRATIVE This Coordinating Center promotes information exchange, resource sharing, and collaboration among investigators in the NCI-supported Small Cell Lung Cancer Consortium, with the ultimate goal of reducing the impact of this disease by facilitating clinical translation toward prevention, early detection, and novel therapeutic research.